Improving PRO Interpretation at the Individual Level for Patients with Cancer using Conversational Agents and Data Visualization

There is increasing recognition of the importance of patient-reported outcomes (PROs) for assessment of health-
related quality of life in both research and clinical settings. PROs are especially important for inherently subjective
but crucial clinical phenomena such as pain, mood, and fatigue. Despite much research in PROs, concerns
about reliability and validity persist, especially when used at the individual level, particularly among patients who
may struggle to understand PRO questions, such as those with low health literacy or undetected cognitive
impairment. Over the past decade, we have developed and tested a tool with the potential to enhance PROs at
the individual level – embodied conversational agents (ECA), which are computer characters that simulate face-
to-face conversation using voice, hand gestures, gaze cues and other nonverbal behavior. We have successfully
used them in behavioral interventions for populations with limited health literacy, elderly patients, and patients
with cancer. Face-to-face encounters, in conjunction with written instructions supported by pictures, remains one
of the best methods for communicating information in general, but is particularly effective for individuals with
limited health literacy. We have also demonstrated that ECAs can be used as valid alternatives to standard
paper-based surveys for substance use screening, and that the display of empathy for patients and other
relational behavior by ECAs leads to increased engagement by patients over time. We will adapt our prior work
on ECAs to produce ECA-PRO, a framework for administering PROs over time using an ECA on patients’
smartphones in English and Spanish. The ECA-PRO system will include novel user interfaces to optimally
communicate the results to patients and clinicians using clear visualizations. To demonstrate the generalizability
of ECA-PRO, we will focus on two clinical scenarios: 1) longitudinal monitoring of symptoms and quality of life in
patients undergoing cancer treatment, and 2) monitoring of medication adherence in patients taking long-term
oral anti-cancer drugs. We hypothesize that the ECA-PRO system, designed for individual-patient-level
interactions and data collection, will improve the reliability, validity, and overall clinical relevance of PROs
collected during cancer treatment. We will develop and evaluate a PRO system that engages patients with
interactive communication and empathy, while delivering standard PROs in a way that minimizes missing data
and enables user-friendly visual sharing of results. The ECA-PRO system will create a strong foundation for
PRO-based clinical decision-making. If successful, these tools can be rapidly and broadly disseminated.

Public health relevance
We will develop and evaluate an Embodied Conversational Agent – Patient-Reported Outcome (ECA-PRO) smartphone system that engages patients with interactive communication and empathy, while delivering standard PROs in a way that minimizes missing data and enables user- friendly visual sharing of results. The ECA-PRO system will create a strong foundation for PRO- based clinical decision-making. This novel system will be tested as a means to monitor symptoms and adverse events in patients with cancer receiving chemo- and/or radiation therapy, and to monitor medication adherence in patients taking oral medication for breast cancer.